Human Subjects and Assessment Core

Abstract
The University of Michigan Human Subjects and Assessment Core (HSAC) provides the infrastructure and
resources critical to UM OAIC investigators performing clinical and translational research. The HSAC is closely
aligned with the UM OAIC’s goal of integrating bench, clinical and outcome research with clinical practice. By
working closely with the LAC, REC, PESC and the three other Resource Cores, the HSAC will assist OAIC-
funded pilots and other externally funded projects (EPs) related to the central research theme of the OAIC.
Important priorities for the HSAC will be to support junior faculty new to aging research, the translation of basic
research discoveries into human studies, and to support high impact clinical trials that have the promise of
reducing disability and improving physical/cognitive function in older adults. The Specific Aims of the HSAC
are: 1. To facilitate access to human subjects and related data sets by investigators implementing research
related to the central OAIC theme; 2. To provide training and consultation to OAIC researchers on issues
related to experimental design (pre- and post-award), recruitment/retention of human subjects, translation from
animal into human studies, techniques to compare national databases; 3. To expand and promote research on
racial, ethnic, and cultural influences affecting the predisposing factors, metabolic/inflammatory mediators, and
functional and health outcomes in older adults; 4. To enhance community engagement in aging research and
facilitate the dissemination of OAIC research in the local community as well as the academic community.